Integrating Evidence-based Approaches to Prevent Child Maltreatment in Kyrgyzstan

1 PROJECT SUMMARY/ABSTRACT
2
3 The purpose of this K01 Award is to provide the candidate with the training and expertise needed to transition to
4 research independence in prevention of child maltreatment (CM). The centerpiece of the project is a proposed
5 study which will use a community-engaged approach to integrate and test three evidence-based programs
6 (EBPs) to prevent CM, domestic violence (DV), and other ACEs in Kyrgyzstan. The project will feature innovative
7 training for the PI in integration and adaptation of EBPs to child/family outcomes, longitudinal intervention
8 research, and quantitative measurement/analysis. It will also feature strong mentoring from group of senior
9 mentors with an outstanding track record of NIH-supported research and an extensive history of mentoring junior
10 faculty, as well as NGOs, all with extensive experience/commitment to preventing CM. Prevention of CM is of
11 paramount importance to individual, family and community wellbeing, particularly among those
12 disproportionately affected, such as families in LMICs, and is relevant for immigrant and refugee populations in
13 the U.S. Although promising approaches exist, they have not been adapted and rigorously evaluated among
14 Central Asian (CA) populations. Although there is strong evidence about the efficacy of these approaches in the
15 general population in the U.S. and other global contexts, these complementary and synergistic approaches have
16 never been deployed jointly in research. To address the needs of the at-risk for ACEs families, the proposed
17 program will adapt and pilot a family-focused (Multiple Family Groups) school-based (School Children and Their
18 Families) economic empowerment (FEE) program to promote positive health and socioeconomic outcomes for
19 children: 1) MFG is a family-centered, group delivered EBP designed for children/adolescents whose families
20 struggle with poverty and associated stressors; 2) SAF has shown to have significant improvements in (co)-
21 parenting and child behavioral outcomes; 3) FEE builds protective factors for individual/family wellbeing by
22 addressing economic stressors and strengthening financial capability. Combining MFG+SAF+FEE is
23 hypothesized to improve child and family wellbeing more than any of the individual interventions’ effects, with
24 each intervention achieving its own specific effects and contributing to the efficacy of the others. These EBPs
25 must be carefully adapted to the culture and distinct needs of the target groups. The proposed study will build
26 on this prior research by implementing these approaches jointly as a package. Carrying out this innovative study
27 in a context of specialized training and mentoring will provide the PI with the skills and experience to leverage
28 community-engaged implementation science for wider application in global contexts. The award will equip the
29 PI to take on a leadership role in the prevention of CM through the use of innovative mixed-method measures in
30 the process of adapting and assessing the most promising approaches to prevent CM in global health contexts.

Public health relevance
PROJECT NARRATIVE Prevention of child maltreatment (CM), exposure to domestic violence (DV) and other ACEs are of paramount importance to individual, family and community wellbeing. To address the needs of families at risk for ACEs, we propose to adapt and pilot an innovative prevention program combining family-focused (Multiple Family Groups or MFG), school-based (School Children and Their Families or SAF), financial economic empowerment (FEE) interventions to promote positive health and socioeconomic outcomes for children and families. Although there is strong evidence about the efficacy of each of these interventions individually in the general population in the U.S. and other global contexts, these approaches have never been deployed jointly or adapted and rigorously evaluated among Central Asian (CA) populations; therefore, the proposed study will adapt and carry out this combined prevention program on a pilot basis in Kyrgyzstan and assess its overall effectiveness qualitatively and through a randomized trial.